Pilot testing a culturally adapted decision aid intervention of supporting Chinese American dementia caregivers in feeding-related decisions

PROJECT SUMMARY (See instructions):
Family caregivers of people with dementia have to decide between tube feeding and hand feeding
when persistent eating problems arise, This decision can be difficult for Chinese-American
dementia caregivers, due to the interplay of culture, potential absence of a patient's advance
directive, poor understanding of dementia, and lack of knowledge on the risks and benefits of tube
feeding. There is a high prevalence of tube feeding among Chinese older adults with advanced
dementia; however, tube feeding does not have health benefits for older adults with advanced
dementia, and may in fact be related to increased risk and discomfort. Shared decision-making is
a process by which patients, family members, and healthcare providers work together to create
care plans that balance clinical evidence and patient preferences and values with risks and
expected outcomes. Current clinical discussions on feeding tubes rarely meet this standard.
Limited research has been conducted to improve decision quality regarding feeding options
among Chinese-American dementia caregivers. The goal of this study is to pilot test a culturally
adapted decision aid intervention to support Chinese American dementia caregivers in decision
making about feeding options. In the R00 phase, the candidate aims to refine and evaluate the
efficacy of the decision aid in a pilot randomized controlled trial among 60 Chinese American
dementia caregivers. By the end of the R00 award, Dr. Pei will complete the transition from
observational and explanatory research to behavioral intervention work and submit an R01
proposal.

Public health relevance
RELEVANCE (See instructions}: This proposed project will test the culturally adapted decision aid intervention to improve decisionmaking about feeding options for Chinese-American dementia patients. If effective, this intervention will indicate the utility of decision aids as a methodology with broader applications to decision-making in end-of-life care in this population.